Understanding formation and dynamics of the SIV reservoir.

ABSTRACT
The suppression of Human Immunodeficiency Virus (HIV-1) from infected individuals is the ultimate goal of
antiretroviral therapy (ART). Major advances have been made towards this end with the advent of ART
regimens. However, despite the sustained suppression of viremia below detectable limits in infected patients
for many years on ART regimens, intact replication-competent virus can still be recovered from a variety of
hidden subterfuges within the host, and most notably from long-lived quiescent memory CD4+ T lymphocytes.
This viral reservoir represents the final impediment to the eradication and clearance of HIV infection or to a
sustained virologic remission in the absence of ART.
Currently, our understanding of HIV reservoirs in patients living with HIV (PLWH) is incomplete. Knowledge of
early reservoir formation and dynamics in the setting of early ART initiation is limited, particularly in anatomic
tissues. My laboratory has shown that persistent viral reservoirs are established very early- within the first few
days after SIV infection (Whitney et al., Nature 2014). While early ART can limit the seeding and expansion of
cellular reservoirs of HIV, conventional understanding is that latent HIV-1 persists primarily in memory CD4+ T
cells. However, studies from my laboratory (Whitney et al., Nat Commun., 2018)
suggest that the contribution of long-lived naïve T cell populations to the intact
were among the first to
viral reservoir is greatly
underestimated, particularly in early seeding and reservoir formation. Similarly, recent work from other groups
have shown that naïve CD4+ T cells contribute to the maintenance of viral reservoir by harboring inducible
proviruses.
Thus, infected naïve CD4+ T cells harboring intact virus serve as an important “proto”-reservoir with an
extended half-life, high proliferative capacity and intrinsic resistance to CTL killing. These observations
underscore the potential of this cell population to renew and maintain the intact reservoir. Combined, these
studies suggest that naïve CD4+ T cells harbor an important and functionally distinct reservoir that is needful of
further investigation for its role in reservoir establishment, persistence and rebound after cessation of ART.

Public health relevance
PROJECT NARRATIVE The majority of HIV-1 infected persons who cease antiretroviral therapy have resurgent viremia due to the presence of long-lived HIV-1 reservoirs. The cell populations and mechanism(s) by which these reservoirs are initially seeded, and then subject to viral rebound upon ART cessation, is not well understood. A detailed understanding of HIV reservoir genesis in CD4+ T cell subsets and how each subset may impact viral rebound is critical to develop approaches to therapeutically foster HIV-1 remission in patients living with HIV-1 (PLWH).